Elucidating Effector CD8 T-Cell – Kupffer Cell InterferonGamma Interaction in Pediatric Activated T-cell Acute Liver Failure

PROJECT SUMMARY- Elucidating Effector CD8 T-Cell –Kupffer Cell- Interferon Gamma Interaction in
Pediatric Activated T-cell Acute Liver Failure
The overall goal of this five-year proposal for a Mentored Clinical Scientist Research Career Development Award
is for me to become an independent academic investigator in the field of liver immunology. After graduating from
Tel Aviv University School of Medicine, I completed my pediatric residency at Children's Hospital at Montefiore.
I then pursued fellowship training in Pediatric Gastroenterology and Transplant Hepatology at Children's Hospital
of Philadelphia (CHOP) and the University of Pennsylvania (Penn). I joined the faculty of CHOP and Penn as an
Attending Physician and Instructor in the Division of Gastroenterology. I continued my scientific training by
completing a Masters in Translation Research at Penn 10/2024. During my fellowship, I developed a clinical and
research interest in why dysregulated immune responses result in Pediatric Acute Liver Failure (PALF). My
mentor for this award, Dr. Edward M. Behrens, is a physician-scientist with a longstanding track record of
scientific innovation and providing exceptional training to mentees. As an internationally recognized expert in
inflammatory disorders, Dr. Behrens's work complements my own, and we are poised for productivity. My
scientific advisory committee includes scientists and physician-scientists with expertise in all aspects of the
proposed work, from CD8 and macrophage biology to next-generation sequencing and spatial transcriptomics.
Scientifically, this proposal focuses on the role of hepatic interferon-gamma (IFN-) response in the most
common cause of PALF, termed Pediatric Activated T-cell Hepatitis/ALF (TC-PALF). TC-PALF is characterized
by an elevated Th1 immune response with a hepatic IFN- transcriptional signature and an abundance of hepatic
effector cytotoxic T lymphocytes (eCTL) expressing markers of tissue residence (CD8+, CD103+, perforin+) and
macrophages. Under the guidance of Dr. Behrens, I previously discovered that hepatic parenchymal response
to IFN- results in exacerbated liver injury in a mouse model of Hemophagocytic Lymphiohistiocytosis (HLH), a
rare autoinflammatory disorder characterized by high circulating IFN- and PALF. However, how specific hepatic
constituents respond to this cytokine in TC-PALF remains unknown. Based on prior literature and my preliminary
data, my central hypothesis is that IFN- directly affects Kupffer Cell (KC) biology and drives liver injury in both
murine and human TC-PALF, independent of its effect on intrahepatic and peripheral lymphocytes. The aims of
this proposal are to establish: 1) the mechanism by which KCs respond transcriptionally and functionally to IFN-
in a murine model of TC-PALF, and 2) the spatial relationship between IFN- responsive KCs, hepatocytes and
eCTLs in both human and murine TC-PALF. This proposal will close major gaps in knowledge regarding the
mechanism by which IFN- acts on hepatic parenchymal cells to develop hepatic-specific therapies and improve
native-liver survival for patients. In accordance with my career development objective to become a field leader
in liver immunology, my scientific proposal complements my current proficiency in cellular immunologic methods
with training in advanced hepatocyte and macrophage biology and bioinformatic methods.

Public health relevance
PROJECT NARRATIVE Immune cells in the liver are important for protecting children from infections. However, when immune cells overreact, the liver can become severely damaged and fail. This project aims to provide crucial information on preventing miscommunication between immune cells and liver cells, ultimately preventing liver failure.